CHARCTERIZ OF BIOLOGICAL ENTITIES: GENE SEQ, MOLEC FINGERPRINT, MAB PRODUCT

Description: Funds are requested to develop a series of support centers and facilities for the identification and characterization of biological entities. The three support centers will render services to those investigators whose research requires (1) monoclonal antibodies and/or fluorescence techniques, (2) fingerprinting, and (3) identification and characterization of genes -automated sequencing, Northern analysis and design, and synthesis of oligonucleotides.